Mentoring Clinical Researchers at the Intersection of NeuroHIV and Substance Abuse

This is a renewal application for a K24 Midcareer Investigator Award in Patient-Oriented Research to support my ability (1) to attract scientists to patient-oriented research at the intersection of neuroHIV and substance use, (2) to prepare a new crop of investigators to tackle complex research questions that require translational approaches and interdisciplinary collaboration, and (3) to foster creativity, insights, and critical thinking in problem-solving approaches to untangle drug effects in neuroHIV. Mentoring and training will be integrally tied to my own research and to the major projects within the HIV Neurobehavioral Research Program (HNRP) at the University of California, San Diego, which are rich sources of data, specimens, and research infrastructure. Mentees will also have access to didactics made available by training programs in which I participate, such as the R25 Interdisciplinary Research Fellowship in NeuroAIDS, which I direct, and a T32 program for Training in Research on Addictions in Interdisciplinary NeuroAIDS, where I am a faculty mentor. I plan to involve mentees in developing new research directions in medical applications of cannabinoids for neuroHIV and explore predictors of central nervous system outcomes in people with HIV who use sedatives and other substances. I will also involve mentees in my continued work on individual differences in vulnerability to CNS dysfunction associated with stimulant use in the context of HIV. I propose additionally to pursue my own professional development to continue to improve my mentoring skills, as well as to enhance my leadership skill set. The superb research environment of the HNRP, along with the larger UCSD HIV and substance use research community, affords opportunities for mentoring and fostering the advancement of early career clinically oriented scientists.

Public health relevance
HIV infection continues to be a cause of neuropsychological impairment for which there are currently no treatments. Support from a K24 Midcareer Investigator Award in Patient-Oriented Research will allow me to develop mew research directions while mentoring clinically-oriented scientists to prepare them for translational research at the intersection of neuroHIV and substance use.